FASEB SRC: Skeletal Muscle Stem Cells and Regeneration

PROJECT SUMMARY
This application seeks partial support for the upcoming Federation of American Societies of Experimental
Biology (FASEB) conference entitled, "Skeletal Muscle Stem Cells and Regeneration", which will be held July
24-28th, 2022 in New Orleans, Louisiana. This will be the 11th edition of this conference focusing on adult
skeletal muscle stem cells (MuSCs) and the 10th sponsored by FASEB. Based on attendance records from
previous years, we expect approximately 175 attendees from around the world of whom ~50% are expected to
be women and ~60% junior researchers. No other scientific meeting has a primary focus on MuSCs. The need
for a conference with this focus is demonstrated by the steady increase in attendance since the meeting's
inception and the consistently excellent post-meeting evaluations provided by meeting attendees. This meeting
attracts all leading MuSC researchers from around the world, further demonstrating its value for established
and future leaders in the field.
The overall objectives of this biennial meeting include: 1) to provide a comprehensive analysis of recent
discoveries in the field, with the goal of understanding the regulatory mechanisms controlling normal and
abnormal functions of MuSCs in muscle homeostasis, regeneration, hypertrophy, aging, and myopathy; 2) to
create and foster an interactive environment for the exchange of ideas and unpublished data, so as to hasten
discoveries and facilitate new and existing collaborations; 3) to provide opportunities for junior investigators to
present their work and network with senior investigators; and 4) to facilitate career development of women and
other underrepresented groups by ensuring representation in all aspects of the conference program.
Our keynote speaker will be Dr. Edward De Robertis, a pioneer in development and stem cell biology. Eight
sessions are planned, presenting 48 speakers (24 invited speakers and at least 24 selected from submitted
abstracts) at all career levels. Session topics include: (i) molecular regulation of MuSCs, (ii) stem cells and
regeneration in diseased muscle, (iii) the MuSC niche and cell signaling, (iv) interaction of MuSCs with, and
regeneration of, the MTJ and the NMJ, (v) dynamics of muscle regeneration, (vi) engineering and translating
MuSCs, (vii) muscle homeostasis and regeneration in aging, (viii) Metabolism and exercise in muscle
regeneration. Invited speakers have been selected for their scientific excellence, with particular attention to
equal representation of women and minorities and geographical diversity. Speakers are explicitly required to
present unpublished work, to ensure scientific discussion is at the forefront of the field. We will have four poster
sessions, each preceded by a “posters blitz” where selected poster presenters will give a one-minute talk to
highlight their work; career-oriented workshops and “meet-the-expert” breakfast and lunch sessions.
This meeting will provide a forum to foster discussion and cross-fertilization from diverse areas of research,
to advance our understanding of muscle regeneration and help in the development of therapeutics.

Public health relevance
PROJECT NARRATIVE Skeletal muscle stem cells, also known as satellite cells, are responsible for the remarkable regenerative properties of skeletal muscle and of very high interest to the scientific community as their study has produced major insights into muscle biology and stem cell behavior generally. This conference, the only one dedicated to this topic, will bring together international leaders in the field, as well as graduate students, postdoctoral researchers, junior faculty, and stem cell biologists from other systems to present and discuss unpublished work in this fast-moving, cutting-edge field. Therefore, this conference has high relevance for human health, as these advances and new ones that will proceed from them will drive work in muscle growth, repair, disease and aging.